Task Order 1: The Interventional Agent Development Services Program

This contract provides for the administrative, management and technical support activities for the NIAID Preclinical Services for the Development of Interventional Agents Program.